CHANGES IN EXTENT OF CORONARY REACTIVITY FOLLOWING CHOLESTEROL LOWERING

To determine the functional severity of coronary artery disease by assessing coronary blood flow reserve and wall motion abnormalities induced by rapid atrial pacing and exercise before and after 2 years of cholesterol lowering, and to assess whether subtle changes in coronary reactivity and/or coronary artery disease are associated with changes in clinical manifestations of the disease.